The Natural History of Autosomal Dominant Osteopetrosis Type 2

Abstract NIAMS Natural Hx Proposal
Abstract
Autosomal dominant osteopetrosis type 2 (ADO2) is a rare osteosclerotic disorder resulting from impaired
osteoclastic bone resorption due to mutations in the Chloride Channel 7 gene, which cause disease by a
dominant negative mechanism. Penetrance is approximately 66% and disease severity varies widely. Affected
individuals typically have at least one significant clinical manifestation including fractures, osteonecrosis,
osteomyelitis, blindness, or bone marrow failure. Ten of our patients have died (out of >80 with clinical
manifestations) either of disease manifestations or from attempts at therapy for severe disease. The natural
progression of disease manifestations in ADO2 is unknown, although limited data suggests that the disease
gets worse with age. Although no effective therapy is currently available, studies in animal models have
generated promising data and human trials on are on the horizon. Therefore, it is imperative to understand the
natural history of ADO2, including reliable biological markers and relevant patient centered outcomes, to
measure therapeutic effect, and to guide the design of clinical trials. The proposed natural history study will
establish a cohort of serially phenotyped subjects to capture clinically important outcomes and characterize
variations in disease severity, progression of disease, and novel biomarkers for current or future disease
severity. The goals of this study are to 1) identify clinically relevant biological (clinical, biochemical,
densitometric, or radiographic) and patient-reported outcomes and 2) determine the natural history of ADO2,
including the rate of disease progression. We will focus on the following specific aims:
Specific Aim 1: Determine key markers of disease severity and endpoints for a clinical trial.
A. Refine and validate a composite clinical severity grading scale.
A. Combine samples and measurements from our prior studies with prospectice serial measurements in
participating subjects to determine which clinical, biological, radiological, and densitometric endpoints best
define current disease severity and predict future disease severity and outcomes.
B. Test the hypothesis that ADO2 disease severity gets worse with age.
C. Compare measures obtained in the studies outlined above in patients with the 3 most common mutations
in our kindreds (G215R, R286W, and R767W) to identify genotype-phenotype correlations, and whether
the individual mutations predict disease severity.
Specific Aim 2: Establish an electronic ADO2 patient registry, which will collect population-based, longitudinal
quality-of-life, pain, disability and other survey-based data from any individual with osteopetrosis. This registry
will serve as a data repository for subjects participating in the research aims above, will provide long-term
follow-up data continuing beyond the completion of this grant, and be an ongoing source of potential
recruitment to future clinical trials of novel therapies.

Public health relevance
Narrative: Autosomal dominant osteopetrosis type 2 (ADO2) is a rare sclerotic bone disorder resulting from impaired osteoclastic bone resorption due to mutations in the Chloride Channel 7 gene. Clinical manifestations include fractures, osteonecrosis (particularly of the jaw), osteomyelitis, blindness, and bone marrow failure. The goals of this natural history study are to 1) identify clinically relevant biological (clinical, biochemical, densitometric, or radiographic) and patient- reported outcomes and 2) determine the natural history of ADO2, including the rate of disease progression, to inform the design of future clinical trials.